New Patient-centered Metric for Transplant Center Report Cards

Project Summary/Abstract
Choosing a transplant center with the best outcomes can be challenging for patients. Several studies suggest
that patients have a choice of centers, but that they are often unaware of how their options may differ. The PI,
as Medical Director of the Scientific Registry of Transplant Recipients (SRTR), provides comparative
information to the public about each solid organ transplant center in the United States. The risk adjusted
outcomes, shown in center report cards, account for the transplant recipient’s health-related characteristics,
donor characteristics and transplant related factors. Many transplant centers provide a print-out of this SRTR
report card to their candidates to comply with Centers for Medicare & Medicaid Services rules. Unfortunately,
in their current format, the center report cards provide three risk-adjusted metrics: survival on the waiting list,
transplant rate, and 1-year post-transplant survival. Our randomized trial has shown that patients often do not
prioritize the metric that is the most important predictor of mortality after listing. Thus, the SRTR report cards
need to be revamped to instead focus on the entire continuum of care from the time of wait listing.
The proposal aims to enhance and evaluate a patient-centered website and printouts of the SRTR report cards
that will effectively communicate comparative information to transplant candidates about survival rate since
listing at different centers. The project will use Dr. Hibbard’s published, conceptual model and develop a new
report card in English and Spanish. Aim 1 will use focus groups to determine how the metric of survival rate
since listing will be presented to transplant candidates clearly in a patient-centered report card. Using this
information, Aim 2 will conduct usability sessions in English and Spanish to develop a patient-centered website
and printouts of the SRTR report card. The new report cards will allow patients to best use both analytic and
experiential modes of thinking to use the new metric for decision-making. Both the English and Spanish website
will include a video navigator and a virtual chat agent to help patients navigate the web-based report cards.
Lastly, Aim 3 will conduct randomized clinical trials (RCTs) in English and Spanish, separately, to evaluate the
effectiveness of the new patient-centered SRTR report card. These RCTs will enroll potential transplant
candidates prior to listing at a transplant center. This study is beyond the scope of the SRTR contract.
At the end of the project, we will help patients choose a transplant center by using the English and Spanish
versions of the new report cards that provide information about survival rate since listing. The new report cards
can improve a broad set of patient-centered outcomes such as effectively navigating the complexity of
transplant centers, improving satisfaction with the center selection process, and potentially reducing death on
the waiting list, — thereby, producing better outcomes in the long run.

Public health relevance
Project Narrative: At the end of the project, we will have enhanced the website and a printout format that the Scientific Registry of Transplant Recipients will use to provide information to the public. We will help patients choose transplant centers by using report cards that provide the new metric, survival rate since listing. The enhanced patient centered report card will work towards improving a broad set of patient-centered outcomes, allowing patients to effectively navigate the health system of transplant centers with varying outcomes, creating greater knowledge, satisfaction with the transplant center selection process, improving access to the waiting list and, in the long-run, improving outcomes.